Molecular Transducers of Physical Activity Consortium Coordinating Center

Project Summary
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) was established to discover the
molecular transducers of endurance and resistance exercise. The Consortium Coordinating Center (CCC),
composed of the Administrative Coordinating Core (ACC), the Biospecimens Repository Core (BRC), the
Exercise Intervention Core (EIC), and the Data Management, Analysis and Quality Control (DMAQC) Core
provides expertise, personnel, and information technology (IT) solutions to support the organization,
administration, planning, standardization, documentation, monitoring, analysis, and reporting of all MoTrPAC
activities. These functions require working closely with the Clinical Sites, the Preclinical Animal Study Sites
(PASS), Ancillary Studies, the Bioinformatics Center (BIC), the Chemical Analysis Sites (CAS), as well as
subcommittees and working groups (WGs). The CCC has developed strategies and processes designed to
integrate activities of MoTrPAC investigators with the input provided by the Data and Safety Monitoring Board
(DSMB), outside experts, and the National Institutes of Health (NIH). The CCC is led by four highly qualified
PIs including Dr. Miller at Wake Forest University School of Medicine (WFUSM) who leads the DMAQC Core
and manages clinical data and safety-related activities, Dr. Tracy at the University of Vermont (UVM) who vice-
chairs the MoTrPAC Steering Committee (SC) and leads the BRC, Dr. Rejeski who resides on the academic
campus of Wake Forest University and leads the EIC, and Dr. Esser who leads the ACC at the University of
Florida and oversees an administrative staff that is the core for managing Consortium-wide communications,
setting-up annual meetings, and supporting subcommittees and WGs. WFUSM is the hub of the CCC, with the
DMAQC Core staff providing project management, computing, and analytical support for all other components
of the CCC. The EIC also assists the DMAQC Core with safety-related activities and is highly integrated with
project managers within the DMAQC Core for supporting clinic-related functions such as Manuals of
Procedures (MOPs), phenotypic measures, certification of interventionists and assessors, and site visits. The
CCC will continue to employ innovative project management tools, programming, and web-based tracking of
recruitment and retention (R&R), interventions, and assessments in real-time. We will capitalize on the
outstanding track record in successfully coordinating, managing, and leading large long-term multicenter
clinical trials involving exercise and other interventions to accomplish the following: (a) facilitate team science;
(b) implement rigor, reproducibility, and transparency in research; (d) acquire, manage, store, and distribute
biological samples for analysis; (e) conduct and coordinate preclinical exercise studies; (f) share resources; (g)
publish results; and (h) lead multidisciplinary teams to implement best-practices for analytical methods applied
to randomized studies. The CCC will facilitate the continued success of MoTrPAC in advancing knowledge
regarding the molecular transducers of exercise as related to public health.

Public health relevance
Project Narrative While there are many important health benefits of physical activity, how exercise exerts its effects is not fully understood. A more comprehensive understanding of the molecular mechanisms underlying the responses to exercise would significantly impact public health. Continuation of the Molecular Transducers of Physical Activity Consortium (MoTrPAC) will achieve its objective of generating a comprehensive map of the molecular responses to acute exercise and exercise training. with a long-range goal of elucidating the mechanisms by which exercise improves health.